Ribonucleoprotein complexes involved in the late phase of HIV-1 replication

Project Summary/Abstract
The overall goal of this project is to understand how HIV-1 packages its RNA genome. During virus assembly,
two copies of the viral RNA are trafficked to the plasma membrane and anchored to assembly sites by a small
number of viral Gag polyproteins (~24 or fewer). The resulting complex functions as a nucleant for further virus
assembly, recruiting additional Gag molecules and promoting budding. Although mechanistic and atomic level
details are unknown, studies suggest that assembly of the Gag:RNA complex is mediated by a combination of
intermolecular interactions between the capsid (CA) domains of Gag, and between Gag’s nucleocapsid domain
(NC) and an RNA packaging signal (ΨCES) located within the 5′-untranslated region of the genome. The proposed
studies aim to (i) identify the structural determinants and mechanism of Gag assembly on the viral RNA
packaging signal during different stages of assembly (supported by the K99). Additionally, the proposal aims to
(ii) collect more structural information of host cell factor interaction, specifically Staufen1, with the viral RNA
(R00), raising potential novel target sites for drug development.
The K99 research, conducted under the mentorship of Dr. Michael F. Summers (primary mentor at UMBC) and
Dr. Owen Pornillos (secondary mentor at the University of Utah), will employ an integrated structural biology
approach, where isotope-edited nuclear magnetic resonance spectroscopy (NMR) will be used to determine key
intermolecular Gag:Gag and Gag:RNA interactions that promote assembly, and Cryogenic Electron Microscopy
to visualize atomic-level details of the Gag:RNA complex that nucleates virus assembly. Mechanistic hypotheses
will be tested by in-cell studies under the guidance of virologist Dr. Alice Telesnitsky (member of the advisory
committee at University of Michigan). Expertise developed in NMR, Cryogenic Electron microscopy, and cellular
techniques will prepare me for an independent career to work within the broader area of host-virus RNP
interactions. Overall, these studies will provide the first structural and mechanistic insights for the
ribonucleoprotein complex that nucleates HIV-1 assembly and its interactions with essential host factors and will
provide Dr. Hollmann skills to establish an independent and inclusive research program.

Public health relevance
Projective Narrative During HIV-1 virus assembly, two copies of the genomic RNA are selectively packaged by a small number of viral Gag polyproteins. Understanding the molecular determinants of this complex that functions as a nucleant for further virus assembly, as well as the understanding of its interactions with host cell factors will extend not only our current understanding about the late phase of infection of HIV-1, but also lead to the development of novel strategies for the treatment of AIDS and potentially even improved gene delivery vectors with greater packaging efficiencies.